The role of H3F3A and ATRX co-mutation in epigenetic dysregulation of developmental genes in pediatric high-grade glioma

PROJECT SUMMARY
Pediatric high-grade gliomas (pHGG), which include diffuse midline glioma (DMG), are among the most lethal
of all pediatric cancers, with survival rarely exceeding two years. The most common mutations in pHGG are
found in histone variant H3.3 (H3F3A), with nearly 50% of all pHGG exhibiting gain-of-function mutations at
either lysine 27 (K27M) or glycine 34 (G34R/V). Both histone mutants result in widespread epigenetic impacts
on transcriptional control and distinct clinical behavior. Additionally, roughly 30% of pHGG harbor loss-of-
function mutations in the chromatin remodeling protein ATRX, which co-occur in about 20% of H3K27M tumors
and 90% of those with H3.3G34R/V mutations. However, there is currently no known mechanism to explain the
gap in co-mutation between the different H3F3A-mutant tumors. Studies have demonstrated the ability of
H3K27M to inhibit the catalytic function of EZH2, an H3K27 methyltransferase, and ATRX has been shown to
impact localization of PRC2, but no such association has been made for H3G34R/V mutations. EZH2, one of
the catalytic subunits of the polycomb repressive complex 2 (PRC2), is responsible for maintaining repression
of many early developmental genes, including those involved in early brain development.
The overall objective of this proposal is to determine how ATRX loss impacts developmental gene expression
in H3G34R/V mutant tumor cells. The central hypothesis states that co-mutation of H3G34R/V and ATRX will
result in (i) inappropriate PRC2 localization and H3K27me3 placement, leading to (ii) expression of PRC2-
repressed neurodevelopmental genes and a subsequent increase in tumor cell growth. The preliminary data
outlined in this proposal suggests that the same set of PRC2 target genes are upregulated both by H3K27M
alone and ATRX loss/H3G34R together. The first aim assesses the role of concurrent H3F3A and ATRX
mutations on PRC2 dysfunction, which will look at both localization and function of PRC2 at known targets and
throughout the genome. The second aim will look into how H3F3A and ATRX co-mutation affects expression of
NPC marker genes and how this impacts cell proliferation and rates of tumor growth. Successful completion of
this proposal is expected to result in a clearer understanding of why ATRX loss is preferentially selected for in
H3G34R/V-mutant gliomas over H3K27M-mutant gliomas. This knowledge will result in the ability to design
and utilize more specific therapies for H3F3A-mutant gliomas, which could prolong survival in upwards of 50%
of pHGG patients.

Public health relevance
PROJECT NARRATIVE Pediatric high-grade gliomas (pHGG), which include diffuse midline glioma (DMG), are among the most lethal of all pediatric cancers, with survival rarely exceeding two years. Mutations in the histone variant H3.3 and loss of ATRX are two of the most common mutations in pHGG, but it is not known how the two interact with each other to impact re-expression of early brain development genes. This proposal aims to look at how the two different histone mutations interplay with ATRX loss to affect developmental gene expression and tumor formation.